Mediators and Moderators of Executive Function Training in Older Adults

PROJECT SUMMARY
This proposal aims to improve the rigor and reproducibility of research on plasticity in human executive
functions (EFs) in older adults, many of which are at risk for developing Alzheimer’s Disease and Related
Dementias (ADRD). We address a critical gap between research and practice that is characterized by a growing
commercial space marketing “brain training” approaches (with EFs being one of the most common targets),
many of which are particularly catering to older adult populations promising to mitigate age-related cognitive
decline or even prevent ADRD. However, despite the growing literature, the current evidence is mixed, with both
methods and findings varying vastly across studies. Here, we address these significant gaps that pose obstacles
to understanding interventions’ reliability and validity by collecting a large-scale open dataset that compares
different training approaches on a common set of outcome measures. This is addressed through 4 independent
aims, all based upon a large-scale study involving new data collection from 1,250 older adults (aged 60+). Aim
1 focuses on determining ingredients that promote adherence and effective engagement with EF training by
examining a set of commonly used ingredients in EF training studies (single vs multicomponent training, standard
vs gamified training, and standard vs. added coaching). We will examine how these ingredients differentially
impact various dimensions of adherence including initiation, implementation, persistence, and effective
engagement. Aim 2 investigates how those ingredients mediate training outcomes, specifically, we test the
differential impact of training conditions on EFs, broader cognition, everyday functions, quality of life, and belief
structures. Aim 3 seeks to uncover individual characteristics that moderate training outcomes. Here, we examine
how adherence and cognitive training outcomes may differ across individuals, and the extent to which this
variability may explain differential outcomes across studies. Aim 4 highlights our goal of promoting open science
through sharing of software tools and data. We will freely share the cross-platform training and assessment app,
research portal, and dataset, that together will promote replication and provide access to other groups using
common outcomes and individual difference variables. Our project goals extend our systematic and
programmatic approach that builds upon successful work in younger adult populations using a citizen science
approach involving thousands of participants, as well as an R21 that has focused on testing the impact of
gamification and the extent to which participant characteristics (i.e., inhibitory control skills) interact with the
implementation of such motivational structures. Our unique and novel large-scale dataset will lead to a robust
and representative understanding of factors that mediate and moderate EF training that will be impactful whether
or not one hypothesizes benefits from EF training. Project outcomes will advance our scientific understanding of
factors impacting effectiveness of cognitive training and help empower older adults with evidence-based and
freely available tools that are effective and genuinely enhance their cognitive resilience and quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding the relevant treatment-related and individual difference factors that contribute to cognitive training benefits would greatly aid the development and evaluation of more personalized treatment regimens for a host of disorders where deficits in cognitive function are amongst the core symptoms (e.g., ADRD in particular, as related to older adults, but also Parkinson’s Disease, Multiple Sclerosis, ADHD, schizophrenia, or TBI). Thus, the proposed research cuts across the bounds of numerous NIH agencies, contributing to the missions of the NIA, NCI, NEI, NIMH, NIAAA, NINCD, NIDA, NINDS, in that all of these agencies work with populations who can gain direct benefits from successful approaches to mental fitness, and the NIH’s greater mission to seek knowledge that will result enhanced health and a reduced burden of disabilities.